Rad-pathomic deep learning models to assist radiologists in differentiating aggressive from indolent prostate cancer on MRI

PROJECT SUMMARY/ABSTRACT
Prostate cancer is the second deadliest cancer for American men. MRI is increasingly used to guide prostate
biopsies and has potential to spare 500,000 men/year from the side effects of invasive biopsies. Yet, subtle
differences in MRI appearance of aggressive vs. indolent (non-lethal) cancer vs. benign tissue creates three
problems: missed cancers, high rates of false positives, and only moderate inter-reader agreement among ra-
diologists. Selective identification of aggressive and indolent cancers is imperative for reducing cancer
death while minimizing side effects from unneeded biopsies.
We propose to develop and use pathology-based (pathomic) MRI biomarkers in rad-pathomic deep
learning methods to assist radiologists in detecting and localizing aggressive vs. indolent cancers on
prostate MRI. In addition, our proposed method will be the first to localize aggressive and indolent cancers
when they coexist (76% of index lesions). We performed four preliminary studies in our unique dataset of
matched radiology and pathology images. First, we found a high agreement in labeling aggressive vs. indolent
cancers between the automated method and two pathologists. Second, we developed pathomic MRI bi-
omarkers from MRI features that correlate with features derived from pathology images. Third, we used the
biomarkers in rad-pathomic deep learning models to detect cancer (AUC: 0.86) and aggressive cancer (AUC:
0.85) on MRI. Fourth, we showed that combining radiologists and the rad-pathomic deep learning models
helped identify 14% more aggressive cancers missed by radiologists.
Three innovations will improve the localization of aggressive vs. indolent cancers on prostate MRI.
First, we will develop 3D RAPSODI, a novel 3D registration method for 3D reconstructed MRI and pathology
images to eliminate the need for slice-to-slice correspondences and map cancer labels from pathology onto
MRI. Second, we will leverage our correlation learning method to identify pathomic MRI biomarkers. Third, we
will use deep learning models to assist radiologists in localizing aggressive cancer on MRI.
Our multidisciplinary team is uniquely positioned to test whether: (Aim 1) pathomic MRI biomarkers empha-
size the visual differences of aggressive vs. indolent cancers on MRI; (Aim 2) rad-pathomic deep learn-
ing models can reliably and automatically distinguish aggressive from indolent prostate cancers on
MRI, and (Aim 3) radiologists assisted by deep learning models have increased detection accuracy and
inter-reader agreement than unassisted radiologists.
Impact: Our proposed rad-pathomic deep learning models have the potential to improve prostate cancer care
in three ways: 1) detecting and targeting aggressive cancers that are currently missed in ~50,000 men/year; 2)
eliminating up to 500,000 unnecessary biopsies/year in men with no cancer or indolent cancers; and 3) reduc-
ing the number of biopsy samples needed to detect aggressive cancers (1-2 vs. 12-18 currently).

Public health relevance
PROJECT NARRATIVE Reliable non-invasive differentiation of aggressive vs. indolent prostate cancer is imperative for the early detection of aggressive cancers (currently missed in ~50,000 American men/year) while minimizing side effects from unneeded biopsies (currently affecting ~500,000 American men/year). We propose to develop pathomic MRI biomarkers and include them in rad-pathomic deep learning models to learn the appearance of aggressive and indolent cancers on MRI from patients with matched MR and pathology images. We will validate our deep learning models when assisting radiologists in detecting aggressive cancers on prostate MRI.